Cochlear Implantation in Children with Asymmetric Hearing Loss or Single Sided Deafness Clinical Trial

ABSTRACT
Challenging auditory environments, e.g., classrooms, school cafeterias, playgrounds, comprise a significant
portion of a child's day. Binaural hearing facilitates speech understanding in these environments where sounds
and speech overlap, originate from multiple sources, and vary in level. Binaural auditory cues are necessary to
understand speech and locate talkers in acoustically complex settings; however, binaural cues are degraded or
eliminated for children with asymmetric hearing loss (AHL, defined as severe to profound hearing loss in one ear
and mild to moderate hearing loss in the other) or single-sided deafness (SSD, defined as severe to profound
hearing loss in one ear and normal or near normal hearing in the other). A cochlear implant (CI) is the only
treatment that can provide hearing to an ear with severe to profound hearing loss and thus, the only opportunity
for binaural hearing. Yet, children with AHL/SSD are not routinely implanted in the poor ear because the better
ear benefits from amplification (AHL) or has normal hearing (SSD). Recently, the FDA granted approval to
implant a subset of children with AHL/SSD; however, the approval is restrictive as it is limited to children with
profound hearing loss and ≤ 5% word recognition in the poor ear. Furthermore, there is no consensus regarding
CI candidacy criteria, assessment tools, or performance outcomes over time for these children. A longitudinal,
prospective, multi-center clinical trial employing an FDA-approved protocol is critically needed to address deficits
of children with AHL/SSD and explore treatment with a CI. Our proposed sequential, two-phase study allows for
comparison of performance growth pre-implant with current hearing aid (HA) technology versus post-implant
with a CI. Aim 1 obtains preliminary efficacy data in children with AHL/SSD who receive a CI in the poor ear.
Post-implant performance with a CI alone is compared with pre-implant performance with a HA. Measures
include word recognition and sound field detection levels. Aim 2 evaluates the effectiveness of bimodal hearing
defined as a CI in the poor ear and a HA in the better ear (AHL) or a CI in the poor ear and normal hearing in
the better ear (SSD). Bimodal efficacy is measured by comparing: 1) post-implant bimodal scores to pre-implant
best-aided scores, 2) post-implant, bimodal scores to better ear alone scores, and 3) change in bimodal
performance across time (CI phase) to change in best-aided performance over time (HA phase). Measures
encompass speech recognition in noise and at soft levels, localization, and Quality of Life metrics. Essential
information related to patient selection, test measures, and methodology will inform clinical management of these
underserved populations. In summary, study outcomes will provide crucial evidence-based data regarding the
development of binaural hearing abilities in children with AHL or SSD who receive a CI in the poor hearing ear,
which is integral to the establishment of standardized treatment.

Public health relevance
Narrative Children who are deaf in one ear and wear a hearing aid or have normal hearing in the other ear struggle with daily communication. A cochlear implant (CI) is the only treatment that can restore hearing to a deaf ear and establish bilateral input, essential for speech understanding in noise and sound localization. Critical information will be gained from this study regarding the CI as a treatment option for this underserved pediatric population.